Structural Biology of Retrotransposition and pre-mRNA Splicing

PROJECT SUMMARY/ABSTRACT
Non-long terminal repeat (non-LTR) retroelements and spliceosomal introns comprise ~70% of the
human genome. Both of these genetic elements are thought to have evolved from a group II intron ancestor.
Group II introns are catalytic RNAs that are able to engage in both retrotransposition and pre-mRNA splicing.
Group II introns engage in retrotransposition and function as retroelements using a copy-and-paste mechanism
that allows insertion into new locations in DNA genomes using a reverse transcriptase (RT) and an intron RNA
template. Despite the prevalence of retroelements in eukaryotic genomes, relatively little is known about the
precise molecular mechanism of retrotransposition. Group II introns are also ancestral to the splicesome,
which is responsible for catalyzing pre-mRNA splicing in eukaryotes. This evolutionary linkage is supported by
the fact that the active site of the group II intron is conserved with that of the spliceosome. Group II introns can
catalyze self-splicing reactions that results in the excision of intron lariat and ligation of the adjacent exons.
There are still many unanswered questions regarding the precise mechanism of pre-mRNA splicing and the
function of highly conserved nucleotides within the active site. Group II introns consist of two major
components that form a ribonucleoprotein (RNP) complex: 1) a self-splicing catalytic RNA and 2) a multi-
functional maturase protein that has RT activity. We have isolated a thermostable group II intron RNP that
exhibits high levels of retrotransposition and splicing activity. Our group II intron complex is very amenable to
high-resolution structure determination and in vitro biochemical studies. To gain mechanistic insight into both
retrotransposition and pre-mRNA splicing, we aim to use single-particle cryo-EM, x-ray crystallography,
genetics and single-molecule approaches to characterize and capture the different stages of catalysis in this
group II intron system. The knowledge gained from these studies will provide direct insight into the
mechanisms of both retroelements and the splicing machinery found in higher eukaryotes. This work also lays
the foundation for the future biochemical and structural investigation of mammalian retroelements. In
summary, the goals of this proposal will further knowledge of the structure and function of genetic elements
that comprise a majority of the human genome.

Public health relevance
NARRATIVE The goal of this research program is to gain detailed mechanistic insight into retrotransposition and pre-mRNA splicing. Retroelements and spliceosomal introns comprise ~70% of the human genome and defects in their function results in many human diseases. We aim to use the molecular insight into these essential genetic mechanisms as a foundation for the development of RNA therapeutics.